CTSA Postdoctoral T32 at University of Utah: Spheres of Translation Across the Research Spectrum (STARS) Training Program

PROJECT SUMMARY
This T32 postdoctoral training program proposes to train 3 postdoctoral trainees annually, totaling 15 trainees
across 5 years. Each trainee will receive funding for two years. We will create a cadre of scholars with
commanding knowledge and experiences across all three translational spheres as well as a deep commitment
to transdisciplinary team science. This T32 will provide the necessary early-career training to produce a
diverse pool of highly trained scientists with the requisite skills to address the nation’s biomedical, behavioral,
and clinical research needs. Our conceptual framework organizes the translational continuum into three
spheres: Discovery, Demonstration, and Dissemination. Scholars undertake and become domain experts
within one sphere and receive training in bridging domains and exposure across the spheres, emerging with a
broad, invaluable perspective of how their research fits within the breadth of translational science and how
discoveries move through the continuum. In addition to domain-specific training overseen by primary mentors,
the T32 program includes training in: (1) core knowledge of translational science research; (2) the value of and
skills needed in team science; (3) how equity, diversity, and inclusion (EDI) contribute to scientific excellence;
(4) research ethics and reproducibility; (4) community engagement; (5) career and leadership development; (6)
grant and manuscript writing; and (7) bridging domains and scientific and lay communication. We are equally
committed to ensuring a diverse group of scholars in order to ensure the pipeline of scientists are as diverse as
the subjects they research. However, recruiting diverse scholars is not enough to ensure an environment
where diverse scholars can thrive. To create such a space, it is critical to teach to all trainees and mentors the
history of racism in science and medicine and how to be an anti-racist scientist. Thus, all trainees and their
primary mentors will receive this training. During their training T32 scholars will receive holistic mentoring and
career guidance from not only their primary mentor, but also secondary, near-peer, and program leadership. In
collaboration with mentors, we will develop a cadre of scholars who are experts in their domains, with a
commanding knowledge of translational science, who have the ability to innovate and advance translation, and
who are skilled communicators, boundary crossers, and team-players with a deep commitment to
transdisciplinary team science. Our overarching goal is to produce a new generation of scientists with strategic
translational emphases whose breadth of knowledge and ability to communicate across boundaries will
increase transdisciplinary cross-fertilization and accelerate healthcare advances.

Public health relevance
NARRATIVE This T32 postdoctoral training program will create a cadre of scholars with commanding knowledge and experience across the translational spectrum as well as a deep commitment to transdisciplinary team science. Scholars will receive a breadth of training as well as holistic and diverse mentoring. This will ensure that they have the knowledge and ability to communicate across boundaries, thereby increasing transdisciplinary cross- fertilization and accelerating healthcare advances.